Cerebral Autoregulation, Metabolic derangement, and Edema in Encephalopathy Outcome (CAMEEO)

Project Summary/Abstract
This K23 award application is for Eric Liotta, MD, a neurointensivist and Associate Professor of Neurology
at Northwestern University. Dr. Liotta’s long-term goal is to become an independent physician scientist with
expertise in the interactions between the brain and the body, in order to improve neurologic outcomes and
reduce the risk of subsequent dementia following acute medical illness. To accomplish this goal, he will pursue
a patient-oriented research agenda focused on delirium and encephalopathy with hepatic encephalopathy (HE)
and COVID-19 associated encephalopathy (CAE) models. His mentored research program leverages career
development activities through applications to the proposed research, culminating in his transition to research
independence. He will develop broadly applicable expertise in systemic metabolic analysis, neurophysiologic
evaluation, cognitive impairment and quality of life outcomes assessment, and patient-oriented research
methods. He has assembled a team of mentors who will guide him in the transition to independent researcher.
Farzaneh Sorond, MD PhD (mentor) is a neurointensivist who studies cerebral autoregulation, aging, and
vascular cognitive impairment; Shyam Prabhakaran, MD MS (co-mentor) is a vascular neurologist who studies
acute cerebrovascular disease with a focus on imaging-based markers of risk; and W. Taylor Kimberly, MD PhD
(co-mentor) is a neurointensivist who studies cerebral and systemic metabolism in acute stroke.
Acute encephalopathy (frequently called delirium) is pervasive in hospitalized patients. Encephalopathy
survivors are at increased risk for cognitive impairment, vascular dementia, and Alzheimer’s dementia, though
the mechanisms are unknown. Treating encephalopathy is hampered by incomplete knowledge of the relevant
systemic derangements and the brain’s physiologic response to those derangements and their clinicopathologic
syndromes. Dr. Liotta will investigate the hypothesis that osmolality and amino acid metabolic derangements
result in cellular brain injury, cerebral edema, and impaired cerebral autoregulation that manifest acutely as
encephalopathy, and chronically as cognitive impairments and elevated risk of early dementia development.
Aim 1 will investigate the mechanism between metabolic derangements and cellular injury, cerebral edema,
and cerebral autoregulation. Aim 2 will investigate the mechanism between cellular injury, cerebral edema, and
cerebral autoregulation and clinical encephalopathy (delirium) severity. Aim 3 will investigate the mechanism
between encephalopathy (delirium) burden and subsequent cognitive impairment. The study will use (1)
repeated assessments of metabolic and physiologic derangements to elucidate the relationship with
encephalopathy severity and (2) longitudinal follow up to investigate the relationship to cognitive impairment. By
completing these aims, Dr. Liotta will gain a substantive foundation in brain-body interactions during acute
illness that can be utilized to elucidate mechanistic targets to reduce cognitive impairment and risk of vascular
dementia and Alzheimer’s dementia following encephalopathy and acute medical illness.

Public health relevance
Project Narrative Episodes of altered mental status, from slight confusion to delirium to coma, are a leading complication of acute medical illness in hospitalized patients and are associated with increased risk of death, long-term cognitive impairment, and increased risk of vascular dementia and Alzheimer’s dementia. This study seeks to improve understanding of the mechanisms that govern the brain’s pathologic response (encephalopathy and delirium) to the metabolic derangements during acute medical illness and how those mechanisms influence cognitive impairment and subsequently increased risk for developing early vascular dementia, Alzheimer’s dementia, or other related dementias after acute medical illness.